Regulatory roles for the Integrator complex and circular RNAs

PROJECT SUMMARY/ABSTRACT
For a protein-coding gene to perform its cellular function, it must first generate RNA transcripts that are
expressed at the appropriate level and properly processed. This is no small feat when one considers that RNA
polymerase II can prematurely terminate and that nascent transcripts can be acted upon by a variety of RNA
processing machines, including ones that yield mature transcripts lacking a canonical 5' cap or 3' poly(A) tail. A
major focus of our laboratory has thus been to identify and characterize novel “non-canonical” processing
pathways that can act on nascent RNAs. Here, we propose to build upon our recent work to study two such
mechanisms that are widely employed across eukaryotic genomes. First, we will mechanistically dissect how
the Integrator (Int) complex catalyzes premature transcription termination at hundreds of protein-coding
genes. Integrator was long known to be critical for the biogenesis of small nuclear RNAs (snRNAs), but we
recently showed that Integrator also binds to many protein-coding loci and attenuates production of their full-
length mRNAs, in some cases by more than 100-fold. This is because the IntS11 RNA endonuclease directly
cleaves nascent mRNAs, triggering degradation of the transcripts and premature transcription termination.
Nevertheless, it remains poorly understood how Integrator is assembled, regulated, and recruited to protein-
coding genes as most of the other subunits in the complex have no known function and lack obvious paralogs
or known protein domains. Our preliminary data indicate that non-catalytic Integrator subunits have distinct
roles at snRNA vs. protein-coding gene loci, and thus we will characterize in detail how these subunits are
recruited and function. Crosslinking mass spectrometry will further be used to define physical interfaces
between Integrator subunits, thereby revealing novel insights into how Integrator is globally assembled and
controlled. Second, we will investigate why many protein-coding genes generate circular RNAs with
covalently linked ends. Some of these non-canonical transcripts are greater than 10-fold more abundant than
their associated linear mRNAs. This suggests the main function of these genes may be to produce circular
RNAs, but the physiological functions of almost all mature circular RNAs remain unknown. We thus will use
high-throughput screening coupled to detailed biochemical studies to identify critical functions for circular RNAs
and their underlying molecular mechanisms. We further will systematically identify factors that modulate
circular RNA levels, especially post-transcriptionally, as very little is currently known about how the fate and
decay rates of these transcripts are controlled. Characterization of these key regulatory mechanisms will not
only provide important insights into endogenous circular RNAs, but may also ultimately enable circular RNAs to
become novel long-lasting therapeutic modalities. In total, these innovative studies will reveal new,
fundamental insights into how the Integrator complex and circular RNAs are regulated and control protein-
coding gene outputs to impact normal and diseased states.

Public health relevance
PROJECT NARRATIVE Protein-coding genes must generate functional RNAs at the appropriate levels, and this process is controlled by many different molecular machines, including the Integrator complex and the spliceosome. The proposed studies will characterize in detail how Integrator controls the amount of RNA that is produced as well as why abundant circular RNAs are generated from many protein-coding genes by the spliceosome. This will allow us to better understand how gene outputs are controlled, thereby providing important new insights into how gene misregulation can lead to disease.